Center for Point-of-Care Technologies Research for Sexually Transmitted Diseases

Project Summary
The long-term goals of our center include addressing the epidemics of STDs/HIV in the U.S.
and in resource-poor settings by development and better use of Point-of-Care (POC) tests, so
as to address health inequity and improve the sexual health of individuals. Our specific aims
are: 1. To develop a “Center of Excellence for the Development and Testing of Point of Care
Tests (POCT) for Sexually Transmitted Diseases (STDs)” with cores that can: drive the
development and application of point-of-care technologies via collaborative efforts that merge
scientific and technological capabilities with clinical need and training of developers, as well
as end users of POCT. 2. To use clinical drivers of technology progression for developing and
expanding existing POC STD technologies, by providing assistance and feed back in an
iterative fashion to developers in a “go-no go” manner, such that we insure that deliverables for
each project are met. 3. To implement functioning core components that work smoothly together
in a collaborative fashion and with other members of the Point-of-Care Technologies Research
Network (POCTRN), which can work with our administrative component to implement a
smooth transition along a pipeline from developmental prototype assays through early in-
house, clinical translation and validation testing, In this coordinated manner, we can assist
with the logical development of POC assays, which prove to have qualifications of sufficient
scientific merit and can progress towards eventual FDA submission and commercialization.
These goals and aims will be accomplished by an effective administrative component,
ascertaining needs of users of POC, training of scientists, funding scientists and engineers for
development of prototype and mature POC technologies, and pilot testing and implementation
of POC tests in diverse clinical settings, which will lead to the commercialization and use of
POC tests for diagnosing STDs in order to improve the sexual health of individuals in the United
States and the rest of the world.

Public health relevance
Narrative Overall Component The relevance of this project to public health is that by use of Point-of Care tests to rapidly and accurately diagnose sexually transmitted diseases (STDs), the sexual health of individuals in both the U.S. and in resource poor settings throughout the world will be improved. Rapid diagnosis and prompt treatment will improve sexual health in the world and prevent the spread of these infectious diseases, by changing behavior and adding to the sexual wellbeing of individuals.